From synapse to function: cocaine-induced cell-type- and circuit-specific accumbal proteome changes

Projection Summary/Abstract
Substance use disorders remain a major public health issue in the US and have proven exceptionally difficult to
treat due to their complex neurobiological underpinnings. Dysregulated signaling within the nucleus accumbens
(NAc) appears to play a critical role in promoting drug-seeking and relapse. Compared to our understanding of
transcriptional responses to drugs of abuse, little is known about the adaptation in the proteomic landscape of
synapses, especially in cell-type- and circuit-specific manners. Such proteomic adaptations are likely to drive
reciprocal interactions between drug-induced transcriptional responses and synaptic dysfunction, thereby
perpetuating the “addiction cycle.” In my career, I will build an independent research program that investigates
the interplay between drug-induced long-term synaptic proteomic adaptations and the underlying transcriptional
responses that drive these adaptations in a cell-type- and circuit-specific manner within the brain’s reward
regions. This proposal will elucidate the synaptic proteome changes in NAc medium spiny neurons (MSNs) in
response to cocaine with unprecedented cellular and circuit specificity. It will then genetically manipulate a
synaptic target to explore its role in cocaine addiction behaviors such as craving and relapse, with the aim of
eventually developing new treatments for substance use disorders. Under the mentorship of Drs. Eric Nestler,
Paul Kenny, and Li Shen, I will behaviorally (cocaine self-administration), cellularly/molecularly (CRISPR), and
bioinformatically determine and characterize the cocaine-induced cell-type- and circuit-specific synaptic
proteome changes in NAc. Experiments proposed in Aims 1 and 2 will also prepare me to examine cocaine-
induced synaptic proteome changes in a circuit-specific manner (mPFC-NAc) in Aim 3 of this award. The
expertise gained from completing these proposed studies, in concert with my strong background in
neuroproteomics and neuropharmacology, will lay the groundwork for my independent laboratory, focusing on
drug-induced synaptic proteomic adaptations and transcriptional responses across reward brain regions with
specificity to drug-type, cell-type, and circuit. By addressing gaps in our understanding of cocaine-induced
synaptic proteomic adaptations and their functional implications in drug-seeking and relapse behaviors, this
research aims to advance targeted therapeutic strategies for cocaine addiction.

Public health relevance
Project Narrative Dysregulated signaling in the nucleus accumbens (NAc) is pivotal in promoting drug-seeking and relapse. However, our understanding of synaptic proteomic adaptations, particularly in cell-type- and circuit-specific contexts, lags behind our grasp of transcriptional responses to drugs of abuse. This proposal aims to explore cocaine-induced synaptic proteome changes in NAc, focusing on their interaction with cocaine-induced transcriptional and epigenetic regulation to elucidate their role in addictive drug-seeking and relapse behaviors.